CE22-003 - A Randomized Controlled Trial Evaluation of the Not a Number Program to Prevent the Commercial Sexual Exploitation of Children (CSEC) and Youth in Minnesota

Although the exact scope of commercial sexual exploitation of children (CSEC) remains
unknown, its significant negative physical and emotional consequences for children has been
well documented. However, there is little evaluation research to guide communities on
prevention best practices and questions remain about what approaches can be effective. Not a
Number (NAN) is a CSEC prevention education program developed by the non-profit
organization Love 146. NAN is being delivered through a train-the-trainer model to groups of
youth in Minnesota at-risk for CSEC. While it is a promising and evidence supported program, it
has yet to be evaluated. The goal of this study is to evaluate the effectiveness of NAN in
reducing rates of CSEC victimization for youth by using a rigorous cluster randomized controlled
methodology in partnership with 24 youth-serving agencies in Minnesota. The research team
will use a Community Based Participatory Research (CBPR) approach to implementing and
understanding the evaluation. The 5-year study will be divided into two components.
Component A (Study years 1-2) will involve: refining the study methodology; conducting a
process evaluation of NAN implementation in Minnesota; qualitative data collection to
understand community perspectives on prevention outcome goals, and pilot testing evaluation
tools and methodology. Component B (Study years 3-5) will involve implementing the
evaluation. Twenty-four youth serving agencies will be paired based on agency and community
characteristics (e.g., agency size, community demographics, rural or urban location). Within
each pair, agencies will be randomly assigned to an implementation condition (NAN
administered within six months of the pre-test) or to a wait-list control condition (NAN program
administered after 6-month follow-up surveys are completed by youth). Approximately 30 youth
will be enrolled in the study per agency (N=720; n=360 per condition), with outcome data
collected at 4 time-points: baseline, 6-week follow-up, 6-month follow-up and 12-month follow-
up. The study, led by an experienced, multi-disciplinary team of researchers and practitioners,
will represent the first rigorous evaluation of a CSEC prevention program. Findings will provide
critical insight into the efficacy of education-based prevention for reducing CSEC victimization
and inform future program development and prevention policy. This study addresses the CDC’s
Research Priority 4 outlined in RFA-CE-22-003.

Public health relevance
PROJECT NARRATIVE The proposed research is highly relevant to public health due to its potential to advance research on preventing the commercial sexual exploitation of children (CSEC). The current study evaluates a promising prevention education program being implemented in Minnesota using rigorous randomized controlled trial evaluation methodology informed by a Community Based Participatory Research (CBPR) approach. Given that there is little evaluation to guide best practice for CSEC prevention efforts, we expect results from this study to directly inform community efforts in this area of public health.